Diagnosis of Cancer in the Emergency Room - Explaining Persistent Disparities - Diversity Supplement

Abstract
Cancer is a common diagnosis in the emergency department (ED) and by the time patients reach the ED, their cancer has
often progressed to later stages. Lung cancer is the deadliest cancer with poor overall survival largely attributed to late
stage at diagnosis and associated comorbidities, particularly among patients with disadvantaged racial and socioeconomic
backgrounds. In preliminary analysis of the parent grant, lung cancer was the most common cancer associated with
emergency diagnosis, late-stage diagnosis, and comorbidities. Chronic obstructive pulmonary disease (COPD), another
smoking related disease, is a common comorbidity and a competing cause of death among patients with lung cancer.
COPD is sometimes complicated by acute exacerbations (AECOPD) that increase disease severity, lung cancer risk and
ED visits. However, little is known about the predictors and outcomes of emergency diagnosed lung cancer (EDLC)
among patients with COPD, especially among those of racial minorities and low socioeconomic status. Further, previous
population-based studies failed to account for important determinants of lung cancer outcomes such as COPD severity and
smoking. Filling a gap in the scope of the parent grant, the proposed supplement will examine the burden and outcomes of
emergency diagnosis of lung cancer (EDLC), as the top emergency diagnosed cancer, with a special emphasis on
comorbid COPD, a condition that affects up to 70% of newly diagnosed lung cancer patients and the exacerbation of
which may precipitate emergency lung cancer diagnosis. First, we will quantify the association between EDLC and
COPD, accounting for smoking, severity of COPD, other comorbidities, and frailty, overall and stratified by race/ethnicity
and socioeconomic status (SES). Second, we will quantify healthcare utilization of lung cancer staging and treatment for
patients with and without EDLC and whether it varies by COPD status, race/ ethnicity, and SES. Third, we will identify
predictors of 1-yr and 3-yr survival after EDLC including patient characteristics and receipt of guideline concordant
treatment. These study aims are nested within the parent grant R01CA264176 using the Surveillance Epidemiology and
End Results Data linked to Medicare data (SEER-Medicare) for Medicare beneficiaries who were diagnosed with lung
cancer between 2008 and 2017. The diversity candidate, Dr. Eman Metwally, is an African American postdoctoral fellow
with a background in Pulmonary and Critical Care Medicine. Through the proposed supplement, Dr. Metwally will gain
skills in healthcare services research, cancer epidemiology, and professional development. Training and findings obtained
from completion of this supplement will result in scientific publications and presentations, skills required to successfully
compete for grant funding, and uniquely position Dr. Metwally to become an independent researcher in lung cancer
epidemiology.

Public health relevance
Project Narrative Cancer is a frequent diagnosis in the emergency department (ED); ED cancer diagnoses are more common among racial minorities and low-income patients and result in poor outcomes, including lower survival. Evidence about emergency diagnosis of lung cancer in the United States (U.S.), and how to prevent it from occurring, is limited. This supplement will generate much needed evidence about emergency diagnosis of lung cancer, focusing on associations and outcomes among patients with chronic obstructive pulmonary disease, and predictors of survival to help identify modifiable drivers of disparities in patients with the poorest prognoses.